Caenorhabditis Intervention Testing Program: Interventions That Modulate Health, Longevity and Aging Hallmarks

Caenorhabditis Intervention Testing Program Renewal--Project Summary
Health challenges linked to human aging take a tremendous toll on society. Physical and cognitive decline limit
the quality of life for the elderly and their caregivers. Aging is the major risk factor for, and possible cause of,
cancer, diabetes, and neurodegenerative disease. Without question, the promotion of healthy aging with
extended resistance to decline and disease should be a major objective of current medical research.
Fortunately, tremendous progress has been made in the biology of aging field and the science is poised to be
translated into preclinical and clinical science.
Simple animals models such as the nematode Caenorhabditis elegans have been at the heart of this success.
Many genes and chemical compound interventions that modulate aging processes are likely to act similarly in
humans. The goal of the proposed work is to continue, and expand, efforts of a co-operative scientific group
involving three closely interacting laboratories who coordinately test pharmacological interventions for their
ability to extend healthy aging and promote longevity in nematodes. A specific emphasis of this integrated
super-group is to test promising compound on a collection of natural variants of the Caenorhabditis genus,
which together represent the extensive genetic heterogeneity in the human population. The idea is that
treatments that confer positive outcomes across a diverse population will have an increased chance of being
effective in humans.
The emphasis of this specific proposal is the screening of test compounds for the capacity to promote longevity
and health across a genetically diverse test set. We will consider compounds via a public access portal, from
leads in the literature, and from high throughput chemical screens for longevity. Our labs will also develop and
test utility of engineered deletions of genes encoding fundamental executors of proteostasis, metabolism,
intercellular signaling and mitochondrial maintenance in diverse genetic backgrounds for compound evaluation.
By creating “at risk’ strains impaired in conserved hallmarks of aging, we might increase the dynamic range for
identifying anti-aging therapies. We will expand understanding of mechanisms for the most effective
compounds, aiding their translation. Overall, we will participate in a unique team project that has the power to
define pharmacological interventions that robustly promote strong healthspan across a varied population, with
implications for development of therapies that promote healthy human aging.

Public health relevance
Project Narrative—Health Relevance This project will identify pharmacological interventions that improve the length of life and/or the quality of aging in a simple animal model that shares many hallmark features of aging in humans. Data obtained at three assay sites by rigorously testing a genetically diverse test set is anticipated to identify chemical treatments with high potential to be efficacious in a diverse human population. Our study may lead to treatments that protect against physical deterioration, cognitive decline, and disease susceptibility in the elderly human population.